Dissecting the molecular mechanism of cytokine activation and spatiotemporal regulation of innate immunity

PROJECT SUMMARY AND ABSTRACT
Macromolecular signaling complexes play fundamental roles in biology, ranging from the control of development
to regulation of the immune system. The inflammasome is an example of a macromolecular signaling platform
that activates the innate immune system in response to invading pathogens or endogenous host-derived danger
signals. As the innate immune system regulates inflammation and has crosstalk with the adaptive immune
system, dysregulation of inflammasome signaling is associated with autoinflammatory and autoimmune
disorders. Activation of the inflammasome involves the recognition of intracellular danger signals by germline-
encoded pattern recognition receptors that then recruit an adaptor protein known as ASC (although in some
instances ASC is dispensable) to form the inflammasome. ASC then recruits a cysteine protease known as
caspase-1 to the inflammasome where it undergoes autoproteolytic maturation. Active caspase-1 then cleaves
substrates that are important for restoring cellular homeostasis, including the interleukin family of cytokines, IL-
1 and IL-18, and the pore forming protein GSDMD to induce a lytic type of cell death known as pyroptosis. The
mechanism of how inflammasomes are assembled, in particular, how the different proteins are organized in
space and time to ensure proper function, is not well understood. Of note, the incorporation of ASC on the
inflammasome is required for cytokine processing, but the mechanism of how ASC induces cytokine activation
has remained unclear for over a decade. Additionally, some inflammasomes are ASC-independent but can form
ASC-containing inflammasomes. How these inflammasomes decide when to form an ASC-independent or ASC
containing inflammasome is a mystery. The goal of this proposal is to address these fundamental questions in
innate immunity. We will elucidate the mechanism of cytokine activation and delineate the spatiotemporal
regulation of inflammasomes. To accomplish this, we have developed new tools that will allow us to build a
spatiotemporal map of inflammasome formation and signaling, which will provide key mechanistic insights to aid
therapeutic development for immune related disorders. Furthermore, we anticipate these tools will become
important biomedical research tools.

Public health relevance
PROJECT NARRATIVE The mammalian innate immune system is essential for host survival, and dysregulation is associated with many human diseases. Activation of the innate immune system is mediated by multiprotein signaling complexes called inflammasomes, but the mechanism of how inflammasomes assemble are not well understood. The goal of this proposal is to systematically map out the assembly of inflammasomes in space and time, which will yield unprecedented mechanistic insights about human immunology that may help develop new treatments for inflammatory diseases and also provide a blueprint for studying other multiprotein signaling pathways.